Understanding transcriptional silencing & anti-silencing mechanisms in Shigella

Project Summary
Nucleoid structuring proteins (NSPs), like the histone-like nucleoid structuring protein H-NS, bind to DNA and
transcriptionally silence genes in bacteria. DNA-binding proteins, known as anti-silencers, counter NSP-
mediated silencing leading to gene expression. These opposing processes govern DNA management and
control transcription in all bacterial cells, impacting many aspects of bacterial physiology, including virulence. In
the bacterial pathogen Shigella flexneri, genes on the 230 kb virulence plasmid are silenced by H-NS and, at
37°C, are anti-silenced by VirB, a required regulator of Shigella virulence. The overarching goal of this project is
to fully understand transcriptional silencing and anti-silencing mechanisms of virulence genes in the bacterial
pathogen Shigella. Over the last project period, a three-step model of anti-silencing has been developed, in
which VirB i/ binds to its site, ii/ spreads along DNA, and iii/ causes a localized change in DNA supercoiling that
evicts or remodels proximal H-NS:DNA complexes, allowing transcription to proceed. Here, our model will be
explored further, based on our new finding that VirB specifically binds an unusual ligand, the nucleoside
triphosphate CTP, like distant relatives in the ParB superfamily. We hypothesize that “The CTP ligand of VirB is
essential for its role as an anti-silencing protein that controls Shigella virulence.” This hypothesis will be tested
using three independent aims. In Aim 1, the role of CTP in VirB:DNA interactions, that underpin VirB-dependent
anti-silencing, will be characterized using biochemical and genetic approaches with innovative elements. Based
on preliminary data, this work will likely identify which of the three mechanistic steps of anti-silencing requires
the CTP ligand. In Aim 2, CTP hydrolysis by VirB will be measured and the effect this has on VirB:DNA
interactions and anti-silencing will be characterized. While the ParB/Spo0J literature, suggests that hydrolysis of
CTP by VirB may cause a conformational change that impacts VirB:DNA interactions, structural differences
highlighted by a new VirB model (collaborator A. Iyer, NIH) make it uncertain if hydrolysis of CTP by VirB has
been retained. Finally, in Aim 3, VirB mutants with intermediate CTP binding activity will be examined to
determine the effects on Shigella virulence. Here, a novel genetic screen allowing the identification of VirB
derivatives with intermediate CTP binding activity will be used so that these VirB derivatives can then be
characterized in assays that measure Shigella virulence. This aim is likely to i/ strengthen the link between CTP
binding by VirB and Shigella virulence and may ii/ provide the first evidence that CTP pools regulate virulence
gene expression. In sum, the proposed work will bring us closer to achieving our stated long-term goal (above)
by specifically examining the role of CTP in the anti-silencing of Shigella virulence genes by VirB. Furthermore,
since the anti-silencer, VirB, is a fast-evolving member of the ParB superfamily that does not participate in DNA
segregation, this work will broaden our understanding of this superfamily; an important group of proteins that
play critical roles in many different bacteria, including those that cause human disease.

Public health relevance
Project Narrative All life forms require their genetic material to be organized and packaged into cells, but this genetic sequestration often silences gene expression. Here, the mechanism that relieves the silencing of virulence genes in the bacterial pathogen Shigella, will be studied by undergraduates and graduate students at the University of Nevada Las Vegas. The primary focus of these studies will be a newly identified ligand of the key anti-silencing protein, VirB.